The role of skull bone marrow-derived CNS macrophages in Rett syndrome.

PROJECT SUMMARY
Rett syndrome is a devastating neurodevelopmental disorder with a significant burden on patients and their
families. Patients present with an initial period of healthy neurological development, immediately followed by
severe motor and cognitive regression during their first few years of life. Patients typically suffer from gait
impairments, loss of speech, seizures, and sleep disturbances. Owing to its primarily neurological presentation,
this X-linked disorder caused by mutations in the methyl-CpG binding protein 2 (MeCP2) has been mostly studied
as a disease of neurons. While MeCP2 loss results in cell-intrinsic neuronal dysfunction, non-neuronal
mechanisms also impact Rett syndrome progression, thus opening therapeutic avenues that bypass
manipulation of neurons. Research over the past decade has shed light on neuroimmune interactions at the
borders of the brain that are critical for healthy brain development and function, suggesting the possibility to
uncover new mechanisms contributing to Rett syndrome. One major advance in the field of neuroimmunology
has been the discovery of the meningeal lymphatic network. Meningeal lymphatic vessels reside in the brain’s
outer membranous layer, the dura mater, where they regulate central nervous system (CNS) fluid volume and
the continuous clearance of cerebrospinal fluid (CSF) out of the CNS. Ablation of these vessels impairs CSF
clearance, resulting in extracellular waste accumulation and cognitive impairment. The clinical presentation of
seizures, increased CSF volume, and inflammatory changes to the composition of CSF in Rett patients, suggests
a potential impairment in the perfusion and clearance of the CSF that normally bathes the brain. Supporting this
hypothesis, our preliminary data shows that CSF perfusion throughout the brain, as well as a major regulator of
normal CSF dynamics, the meningeal lymphatics, is largely absent in an MeCP2-deficient mouse model of Rett
syndrome. Here, we propose to test the hypothesis that the loss of meningeal lymphatics, resulting from a loss
of meningeal macrophages, is an important contributor to Rett syndrome. Our preliminary data suggest that this
decreased meningeal lymphatic coverage may result indirectly from the loss of meningeal macrophages, which
typically provide trophic support to lymphatic vessels. Our data also points to an upstream, cell-intrinsic
impairment in bone marrow hematopoiesis, or immune cell production, as the mechanism responsible for the
observed loss in meningeal macrophages. The first aim will employ state-of-the-art transgenic mouse lines to
study the cell type specific effects of MeCP2 loss on skull bone marrow hematopoiesis and macrophage
differentiation. The second aim will employ advanced cell replacement strategies and viral overexpression tools
to assess the functional relationship, as well as therapeutic potential, of meningeal macrophages and lymphatics
in Rett syndrome. This work has the potential to both uncover new biology that is critical to Rett syndrome
progression and identify new and accessible therapeutic targets to help ameliorate disease.

Public health relevance
PROJECT NARRATIVE Rett syndrome is a devastating neurodevelopmental disorder characterized by neurological regression and multi- organ dysfunction. Given the limited therapeutic options for Rett syndrome, it remains imperative to broaden our understanding of non-neuronal mechanisms contributing to disease. This proposal focuses on the role of meningeal lymphatic vessels and impaired CSF clearance in Rett syndrome, with the potential to uncover a novel therapeutic target for the treatment of this disorder.